Evaluating the role of stigma in polysubstance use and medication for opioid use disorder treatment in an underserved, rural setting

Project Summary/Abstract
Overdose rates related to opioid and stimulant use have been steadily increasing in
underserved, rural areas of the U.S. for over 10 years. Addressing this gap in care, our team
has successfully increased access to buprenorphine care through telemedicine aboard a mobile
treatment unit (MTU) in rural Maryland. However, retention aboard the MTU remains a
challenge, similar to other medication for opioid use disorder (MOUD) programs across the
nation. Furthermore, polysubstance use, which is heavily prevalent in the MTU populations, has
been found to exacerbate MOUD retention challenges. Stigma around substance use (SU) and
MOUD is an established barrier to engagement in opioid use disorder and MOUD care.
However, little is known regarding how SU and MOUD stigmas manifest and impact patients in
rural settings. Given their shared, lived experience, peer recovery specialists (PRSs) may be a
unique solution to shifting stigma barriers. Yet, few studies have examined if and how PRS
engagement shifts stigma, particularly in underserved, rural communities. Thus, this study aims
to: (1) use a qualitative approach to understand how substance use and MOUD stigmas impact
patients and their treatment, as well as perspectives on the role of PRSs in shifting stigma, in an
underserved, rural setting; (2) evaluate if and how baseline levels of stigmas impact six-month
MOUD retention rates in this sample; and (3) assess if engagement in a PRS-delivered BA
intervention shifts stigma.

Public health relevance
Project Narrative Rural areas of the U.S. experience a disproportionate burden of overdose rates related to opioid use and stimulant use, yet access to care remains limited. Despite innovative methods to increase access to medication for opioid use disorder (MOUD) in a rural setting, retention remains a challenge. Understanding and addressing the impacts of stigma on MOUD retention may be vital in supporting long-term outcomes in this setting.